Immunoglobulin-Driven Activation of the Complement Cascade is a Critical Determinant of PAH Initiation and Progression

There is convincing evidence for both inflammatory and autoimmune phenomena to be involved in the
pathogenesis of PAH. However, both the triggering and the disease sustaining mechanisms remain elusive.
Based on emerging evidence in other diseases, including arthritis, kidney disease, and cancer, generated
by Co-Investigators on this project, it has become clear that the Complement system, when dysregulated,
can become a potent instigator of inflammation-driven tissue injury. Our recently published data
demonstrated, we believe for the first time, that the immunoglobulin-driven activation of the complement
cascade, specifically its alternative pathway, in the pulmonary perivascular areas is a critical mechanism
initiating pro-inflammatory and pro-proliferative processes in experimental hypoxic PH (a form of “sterile
inflammation”). We also demonstrated that the activated complement cascade and immunoglobulin G (IgG)
deposition are persistent determinants of the disease. The present proposal builds on these findings and
comprises both mechanistic and translational arms. In Aim 1 we will evaluate the role of immunoglobulins
and complement in initiation of pro-inflammatory processes in PH. In Aim 2 we will evaluate the role of
immunoglobulins and complement in the sustained progression of vascular injury and the disease process. In
a potentially highly translational Aim 3 we will test the efficacy of targeted (local) complement inhibition in
experimental PH using a novel complement inhibitor, human fusion protein termed TT32, which can be used
to target local activated complement signaling.

Public health relevance
Persistent perivascular inflammation is observed in many forms of pulmonary hypertension and is now thought to contribute significantly to both the overall vascular remodeling and high pulmonary artery pressures that characterize this lethal disease process. We show that early activation of complement occurs in PH and that this activation is critical in the early recruitment and persistence of inflammatory cells. The purpose of our project is to determine the mechanisms contributing to early and persistent complement activation and to determine if complement activation, in the vessel wall, can ultimately be targeted to ameliorate the disease process.